Working towards targeted therapy in H3K27M tumors: Aurora Kinase Inhibitors and the role of epigenome programming

PROJECT SUMMARY
Tumors affecting the brain result in more cancer-related deaths than any other type of tumor in children. It is
therefore critical to identify new therapies for these deadly diseases. Among pediatric patients, one of the most
devastating brain tumor types is diffuse midline gliomas with the H3K27M mutation, which includes the
previously named Diffuse Intrinsic Pontine Glioma (DIPG). Our understanding of this deadly disease has
recently been advanced by important discoveries, including the finding that almost all of DIPG tumors harbor
the histone H3K27M mutation. This mutation results in global hypomethylation of H3K27 residues and is the
pathological hallmark for this disease. How the H3K27M mutation is important for tumorigenesis is still being
elucidated. At Mayo Clinic, we have shown that H3K27M mutation reprograms gene expression and histone
methylation patterns, and is a key driver for these deadly tumors. We hypothesize this mutation creates unique
therapeutic vulnerabilities, which can be exploited to develop novel therapies. In an effort to discover potential
drug targets for H3K27M tumors, we performed a large scale drug screen which identified aurora kinase
inhibitors (AKI) as a potent class of drugs that decreased the proliferation and survival of H3K27M tumor cell
lines. Further testing revealed epigenetic changes with AKI treatment including restoring H3K27me3 levels,
and decreased H3S10 and H3S28 phosphorylation. Testing of the aurora kinase A inhibitor alisertib in an
orthotopic patient derived xenografts showed decreased tumor size, increased survival and on-target drug
effects within the tumor.
Based on these exciting results, we hypothesize that inhibition of Aurora Kinase is a targeted approach for
treating tumors with the H3K27M mutation. In this proposal, we will elucidate how the H3K27M mutation effects
mitosis, the mechanism how AKIs modulate the cell cycle and arrest of mitosis and understand the
radiosensitizing effects of these drugs. Next we will understand the molecular mechanisms how aurora kinases
modulate the epigenetic landscape and gene expression before and after inhibition. Finally, we will perform the
necessary preclinical studies in animal models to support translational efforts in the clinic. We have assembled
the necessary team required to successfully complete this project: including Jann Sarkaria, a radiation
oncologist who specializes in translational animal research for high-grade gliomas, Ted Hinchcliffe, an expert in
mitosis from the Hormel/University of MN, Steven Johnsen, an expert who studies epigenetic regulation in
cancer, and the PI, David Daniels, a pediatric neurosurgeon and medicinal chemist, who has developed
numerous H3K27M cell lines and studies drug delivery to the brainstem. We believe, together, the proposed
studies and team, will not only make basic scientific discoveries aimed at understanding the molecular basis of
tumorigenesis, but also lay the foundation for effective therapy for this deadly disease.

Public health relevance
PROJECT NARRATIVE Diffuse midline gliomas with the H3K27M mutation, which includes the previously named Diffuse Intrinsic Pontine Glioma (DIPG), are the most aggressive primary malignant brain tumors in children with the median survival of this group about one year after diagnosis with no effective therapies available. Recent studies have identified somatic mutation of the H3F3A gene that encodes the histone H3 variant, H3.3, which results in lysine 27 to methionine change (K27M) in the encoded protein H3.3 in most DIPG tumors. The planned studies will not only make basic scientific discoveries aimed at understanding the molecular basis of tumorigenesis, but also lay the foundation for molecularly targeted therapies for this deadly disease.